Identifying a transcriptional core regulatory circuitry and other critical transcription factor dependencies in H3.3 G34R/V high-grade glioma

Project Summary
Pediatric high-grade gliomas (HGGs) are devastating central nervous system malignancies. Despite decades of
investigation into these lethal childhood brain tumors, aggressive surgical resection combined with conventional
chemotherapy and radiation therapy remains the standard of care. Unfortunately, this treatment approach has
failed to improve the 5-year survival of patients with cortical HGGs, which continues to be less than 20%. The
paucity of curative treatment options for patients with HGGs emphasizes our urgent need to further understand
these disease entities at the cellular and molecular level for informed therapeutic approaches. The identification
of recurrent histone H3 mutations in pediatric HGGs by my mentor Dr. Suzanne J. Baker and others strongly
supports a critical role for epigenetic dysregulation in the etiology of childhood HGGs. Recurrent Gly34Arg/Val
substitutions in histone H3.3 (H3.3 G34R/V) occur in more than 15% of cerebral cortex HGGs found in
adolescents and young adults. The frequency of these mutations in a subset of cortical HGGs underscores the
functional significance of epigenetically dysregulated spatiotemporal gene regulatory programs during
development. However, the impact of H3.3 G34R/V on transcriptional regulatory programs contributing to
tumorigenesis in a distinct spatiotemporal context within the developing brain remains to be determined. This
proposal integrates the expertise of the Baker lab for functional and mechanistic studies in HGG with the
pioneering expertise of a group of collaborators who have identified and functionally validated transcriptional
core regulatory circuitries (CRC) and other critical tumor dependencies in models of pediatric cancer. By
combining cutting-edge genomic platforms and other experimental techniques with clinical training experiences
in pediatric neuro-oncology and neurosurgery, I intend to decipher complex transcriptional patterns dysregulated
in H3.3 G34R/V HGG to address current limitations in treating this intractable central nervous system
malignancy. The Baker lab established a novel collection of age and anatomically matched primary tumors,
patient-derived orthotopic xenografts, and a range of cell lines modeling wild-type, mutant, and CRISPR-
corrected H3.3 backgrounds for experimental interrogation of transcriptional dysregulation in HGG. Aim 1
leverages chromatin-based assays and RNA interference to identify transcription factors (TF) comprising a
transcriptional CRC essential to maintaining an oncogenic cellular state in H3.3 G34R/V HGG. Aim 2 employs
CRISPR/Cas9 negative selection screens to comprehensively target TF DNA-binding domains in patient-derived
cell lines from H3.3 G34R HGG and expands beyond core TFs comprising a transcriptional CRC to uncover
other critical TF gene dependencies in H3.3 G34R HGG. The identification of critical TF gene dependencies in
H3.3 G34R/V HGG will enhance our understanding of cancer cell dependency on transcriptional regulatory
programs and illuminate potentially actionable biology for the development of novel therapeutic strategies.

Public health relevance
Project Narrative High-grade gliomas of the cerebral cortex are intractable brain tumors with a 5-year survival of less than 20%. Recurrent Gly34Arg/Val substitutions in Histone H3.3 (H3.3 G34R/V) occur in more than 15% of cerebral cortex high-grade gliomas found in adolescents and young adults. This proposal aims to determine the impact of H3.3 G34R/V mutations on transcriptional regulatory patterns contributing to tumorigenesis and identify critical transcription factor dependencies by leveraging a novel collection of primary tumors, patient-derived orthotopic xenografts, and a range of patient-derived cell lines modeling wild-type, H3.3 G34R/V mutant, and CRISPR- corrected H3.3 G34R/V backgrounds.